Studies of direct and transthalamic pathways in visual cortex

PROJECT SUMMARY
Few structures in the brain are as prominent, yet poorly understood, as the pulvinar. The pulvinar is both large
and complex, having undergone more expansion with primate evolution than any other thalamic nucleus. Based
on its reciprocal connections with the full extent of the visual hierarchy, from primary visual cortex through
inferotemporal cortex, the pulvinar is strategically positioned to facilitate/mediate the communication of visual
signals between cortical areas. These transthalamic pathways operate in parallel to the direct corticocortical
pathways. The main goal of this research is to understand the functional organization of the separate direct and
transthalamic pathways that cortical areas use to communicate with one another. For this, we use the mouse and
monkey visual systems and study the connections between the primary and secondary visual cortical areas (V1
and V2) in each species. We use optogenetic tools to selectively inhibit one or the other pathway from V1 to V2.
We study the effects of such inhibition on the animals’ ability to perform various visual tasks as well as on
responses to visual stimulation among V2 neurons. A major goal is not only to identify functions for the direct
and transthalamic pathways, but also to compare these among such disparate mammalian models as mice and
monkeys with the hope of generating insights into the functioning of these cortical processes that are common
to mammals. Given the severe financial and quality-of-life consequences that follow from disruption in the ability
of cortical areas to communicate properly with each other, such as occurs with many forms of epilepsy, stroke,
and illnesses affecting vision and thalamocortical function, it is important that we understand how the thalamus
and cortex interact to meet the processing needs of the brain. The proposed study will have a major impact on
our understanding of higher order thalamus, cortical communication, and substrates for disease and
dysfunction.

Public health relevance
PROJECT NARRATIVE Communication between cortical areas is thought to occur via direct and transthalamic pathways. The specific functions(s) of each pathway and their relative contributions to cortical communication are important and unresolved questions. Given the severe financial and quality-of-life consequences that follow from disruption in cortical communication and thalamic processing, such as occurs with many forms of epilepsy and illnesses affecting vision, it is important that we understand how the thalamus and cortex interact to meet the processing needs of the brain.